The Role of Cyclooxygenase-2 in Salt-Sensitive Hypertension

Essential hypertension is a major source of morbidity and mortality in the general population, and a
significant percentage of hypertensive patients manifest salt-sensitive hypertension. Although the
etiology of salt-sensitive hypertension is undoubtedly multifactorial, there is experimental and
epidemiologic evidence linking abnormalities in the cyclooxygenase (COX)/prostaglandin system to its
pathogenesis. COX-2 inhibitors, as well as non-selective non-steroidal anti-inflammatory drugs (NSAIDs),
are known to elevate blood pressure (BP) and antagonize the BP-lowering effect of antihypertensive
medication in many users. A COX-2 polymorphism that reduces enzymatic activity has been associated
with increased risk of stroke in African Americans. Selective inhibition of COX-2 has been implicated in
increased cardiovascular mortality, which appears to be multifactorial, and may involve increases in BP
and salt and water retention in addition to accelerated thrombogenesis. Therefore, COX-2 activity seems
to be an important mediator of salt and water homeostasis and a guard against development of salt-
sensitive hypertension. The mechanism by which COX inhibition leads to development or exacerbation
of hypertension has been attributed to inhibition of renal COX-2 activity, since salt loading up-regulates
COX-2 expression in the renal medulla, and COX-2 inhibitors reduce urinary sodium excretion. However,
there continues to be controversy about the cellular origins and regulation of the COX-2-derived
prostaglandins that regulate salt and volume homeostasis. Our recently published and preliminary results
provide a novel paradigm to be tested: that COX-2-derived prostaglandins from renal medullary
interstitial cells (RMICs) and renal resident macrophages/dendritic cells work in parallel to
regulate salt and water and blood pressure homeostasis and that abnormalities in either can lead
to development of salt-sensitive hypertension. To test this hypothesis, we propose three specific
aims:
Specific Aim I Investigate the Functional and Structural Roles of COX-2 Expression in Renal
Medullary Interstitial Cells (RMICs)
Specific Aim II Determine Mechanisms by Which Inhibition of Renal Macrophage/Dendritic Cell
COX-2 Expression or Activity Can Potentiate Salt-Sensitive Hypertension
Specific Aim III Determine the Potential Physiologic Role of Renal Macrophages/Dendritic Cells in
Response to Chronic Volume Depletion
!

Public health relevance
The proposed studies will investigate the roles of prostaglandins derived from cyclooxygenase-2 (COX-2) in regulation of salt and water homeostasis by the kidney and will investigate how inhibition of COX-2 can potentiate salt-sensitive hypertension. The overriding hypothesis to be tested is that expression of COX-2 in medullary interstitial cells intrinsic to the kidney and in renal resident macrophage/dendritic cells together mediate prostaglandin-mediated regulation of salt and water by the kidney.